Transduction of Psychological Stress into Systematic Inflammation by Mitochondrial DNA Signaling

PROJECT SUMMARY
Systemic inflammation is believed to contribute to the damaging health effects of psychological stress. In the
laboratory setting, a single acute bout of socioevaluative stress leads to a delayed elevation of pro-
inflammatory cytokines in healthy adults. However, the biological mechanisms by which psychological stress is
transduced into inflammation is not well understood. A cellular component known to contribute to stress
signaling is the mitochondrion – a bacteria-derived organelle with its own genome, the mitochondrial DNA
(mtDNA). Recent evidence has demonstrated that various stressors induce the release of mitochondria-
derived signaling molecules, or mitokines. Mitokines travel systemically and modulate central physiological
processes, including immune cell function and the production of pro-inflammatory cytokines. One key mitokine
is circulating cell-free mtDNA (ccf-mtDNA), which arises from mitochondrial extrusion of mtDNA, is recognized
by the toll-like receptor 9 (TLR-9), and leads to pro-inflammatory cytokine production in animal and human
cells. Our preliminary data showed that ccf-mtDNA release, but not ccf-nuclear DNA, is acutely induced
following a brief experimental psychological stress in humans. Thus, we suggest that ccf-mtDNA may be a
missing link in the stress-inflammation cascade. In parallel, imaging and molecular studies on cellular systems
suggests that ccf-mtDNA may be rapidly induced by primary neuroendocrine stress mediators, including
glucocorticoids. This proposal will use an experimental socio-evaluative stress task, counterbalanced with a
control no-stress visit for each participant, to map the kinetics of reactivity and recovery in ccf-mtDNA and
other stress mediators in healthy women and men. Aim 1 will establish: i) the magnitude and kinetics of ccf-
mtDNA release; ii) the specificity of this response compared to nuclear DNA; iii) examine potential sex
differences in this process; and iv) statistically test ccf-mtDNA as a mediator of the subsequent increase in pro-
inflammatory cytokines. In Aim 2, cellular and molecular studies will determine: i) whether primary
glucocorticoid and catecholamine stress hormones are sufficient to trigger ccf-mtDNA release in primary
human cultured cells and isolated leukocytes; ii) image in living cells mtDNA release in response to stress
signaling; and iii) document physical changes in mtDNA structure that contribute to ccf-mtDNA release. Finally,
Aim 3 will establish: i) the capacity of ccf-mtDNA from peak ccf-mtDNA serum to activate cytokine production in
target cells; ii) the structural form and accessibility of ccf-mtDNA in human serum (from Aim 1); and iii) the
dependency on TLR-9 for immune activation. Overall, these studies will contribute mechanistic evidence for a
novel mitochondria-mediated mechanisms for transducing stress into inflammation in humans. Outcomes from
this work will identify new potential targets to improve stress-related mental health and inflammatory disorders.

Public health relevance
NARRATIVE There is a long-standing need to understand how adverse psychosocial experiences, such as psychological stress, are biologically transduced into systemic inflammation and increased disease risk. This proposal builds upon recent mounting evidence of a stress-mitochondria-inflammation axis, and investigates the role of mitochondrial DNA signaling in stress-induced inflammation. The interdisciplinary work proposed will identify a series of potentially modifiable physiological, cellular, and molecular mechanisms and provide a robust empirical foundation for the developing field of mitochondrial stress pathophysiology.